Clinical Research Training for Psychologists

This program seeks to prepare clinical psychologists for scientific careers in a variety of academic settings. Psychologists, who are well versed in psychological theory, experimental methodology, and quantitative skills, possess talents that are critical for conducting clinical research. Nevertheless, additional preparation is needed to enable psychologists to work effectively on multidisciplinary teams, address current challenges in the field of mental health, and compete successfully for independent research funding. Accordingly, in this competing renewal application, we propose to continue and refine an existing, integrated program of predoctoral and postdoctoral training for promising clinical psychological scientists. By recruiting graduate students in clinical psychology who have demonstrated scholarly accomplishments, we are uniquely positioned to identify and prepare talented psychologists for academic careers.

Public health relevance
The goal of this training program is to train psychological clinical scientists to conduct research that will promote the scientific and training priorities of NIMH and enhance the public health. Clinical psychologists are well-qualified to promote the translation of research findings to the clinical setting in meaningful ways because they have been in the forefront of the development of efficacious treatments that incorporate evidence-based mechanisms associated with specific psychopathology. This training program seeks to capitalize on the unique foundational skill set of clinical psychologists and to further equip these scientists to make meaningful scientific contributions to enhance mental health across the lifespan.